National Center for Rehabilitative Auditory Research

The Center model employed by the National Center for Rehabilitative Auditory Research (NCRAR) uses
core funding to provide infrastructure that supports core investigators, who then leverage this support to garner
external peer-reviewed funding, and to support education/outreach activities. Research is planned in the areas
of Diagnosis and Assessment, Rehabilitation, and Prevention of auditory and balance dysfunction in Veterans.
Education/outreach programs will include biennial conferences, a monthly seminar series, NIH-funded T-35
audiology student research training, and year-long externships for 4th year Audiology doctoral, Au.D., students
in collaboration with the VA Portland Health Care System (VAPORHCS) Audiology Service. Technology-wise,
further development in commercialization is planned for NCRAR's OtoID, a patented high-frequency portable
audiometer, and for an upgrade to the patented Tinnitus Evaluation System (TES) to a tablet form factor, which
would enable it to be used either in the clinic or in the Veteran's home. Some examples of studies planned in
each of three key research areas are:
Diagnosis and Assessment 1) characterize the impact of cochlear outer hair cell loss on physiological
indicators of synaptopathy resulting in so-called “hidden hearing loss”, and clarify the perceptual consequences
of this type of auditory damage; 2) study the pathophysiology and clinical phenotype of decreased sound
tolerance (DST) and evaluate its auditory and psychological biomarkers; 3) evaluate the effects of blast
exposure, TBI, and PTSD on hearing, tinnitus, and balance disorders over Veterans' lifetimes as part of the
larger “Long-term Impact of Military-relevant Brain Injury Consortium (LIMBIC)” DoD/VA study; 4) use the
computer-automated TES to expand normative data for the proper interpretation of tinnitus psychoacoustic
testing; and 5) evaluate the ability of the brain to merge vestibular and visual streams of sensory information
correctly in time to maintain balance and orientation.
Rehabilitation 1) evaluate the long-term acclimatization effects obtained with hearing aids to improve
hearing aid success among Veterans, and evaluate the effects of combining tests of speech understanding in
noise, electrophysiology, behavioral tests of cognition, and tinnitus benefit to determine the changes in
perception that occur after a hearing aid fitting; 2) evaluate the use of low-gain hearing aids for the
management of tinnitus and their effect on communication in Veterans with normal or near-normal hearing; 3)
adapt an interprofessional model for diagnosing and treating somatosensory tinnitus for a VA population; 4)
participate in two collaborative multi-site randomized clinical trials of prescription medications for the treatment
of tinnitus; 5) evaluate the ability of “stochastic resonance” supplied by a small amount of electrical current to
increase the sensitivity of the damaged vestibular system and increase its effectiveness in older people with
imbalance.
Prevention 1) evaluate the use of new extended high frequency transient evoked otoacoustic emission
tests and sensitized speech tests conducted using mobile devices for monitoring aminoglycoside ototoxicity,
which may also be useful in evaluating new otoprotectants; 2) examine the epidemiology of noise-induced
hearing loss and tinnitus in recently discharged Veterans and active duty Service members to uncover various
exposures that are more strongly associated with tinnitus and hearing loss and could, therefore, be targeted for
prevention efforts both in and out of the military; 3) explore the use of automated adult hearing screening in the
primary care setting using the results of a recently completed clinical trial; and 4) explore the genetic markers
for chemotherapy-induced ototoxicity.
KEYWORDS: hearing loss, tinnitus, postural balance, diagnosis, rehabilitation, primary prevention, sensory
aids, translational research

Public health relevance
Research conducted at the National Center for Rehabilitative Auditory Research (NCRAR) involves the diagnosis and assessment, rehabilitation and prevention of auditory and balance dysfunction. It is highly relevant to Veterans' health care because tinnitus and hearing loss are the number one and number two most prevalent service-connected disabilities, respectively, among all Veteran compensation recipients (Veterans Benefits Administration, 2019). Moreover, balance dysfunction is associated with blast exposure and traumatic brain injury often seen in Veterans of recent conflicts. Additionally, since nearly half of all Veterans are over age 65 (VA Strategic Plan 2018-2024), NCRAR research will remain relevant to Veterans' health because it focuses on the assessment and diagnosis, rehabilitation, and prevention of tinnitus, hearing loss and balance dysfunction, which are all disorders prevalent in aging Veterans.